VET-Spirit: A Pilot Feasibility and Acceptability Trial to Address Spiritual Needs in Seriously-Ill Veterans

Background: Seriously-ill veterans rely on spiritual and existential beliefs to cope with their
illness, support their quality of life, and make critical healthcare decisions. As a result, VHA
(Directive 1111) and other major health care organizations mandate spiritual assessments. With
VA funding, our research team developed and validated the first quantifiable spiritual screening
tool designed specifically for seriously-ill Veterans, VET-Spirit. The crucial next step is integrating
screening and response to spiritual needs into serious illness care. This proposal develops and
evaluates the feasibility and acceptability of implementing VET-Spirit, which systematically
measures spiritual needs and subsequently equips providers with spiritual needs data into
clinical care. VET-Spirit includes a curated summary of VET-Spirit patient response data to
providers with communication prompts to aid in discussions of unmet needs. We hypothesize:
80% of veteran enrollees will complete VET-Spirit measure; 75% of providers rate AIM, FIM and
IAM items at a mean of four or above on a five-point likert scale indicating agreement with
acceptability, feasibility and appropriateness of the implementation strategy. Significance/
Impact: While the VHA mandates spiritual care, VA’s use neither a common: 1) screening tool,
or 2) process for integrating identified needs into care. VET-Spirit includes both. Innovation: 1)
Ensuring Compliance - No previous intervention has been designed to assess the spiritual
needs and resources of seriously-ill veterans, curate that information, and deliver it to the care
team. Integrating an actionable spiritual screening tool into the stream of care enhances care
coordination and places the VA at the forefront of care of seriously-ill veterans. 2) Spiritual Care
Accountability - VET-Spirit creates and evaluates a process for patient-centered care by
integrating screening of spiritual beliefs into serious illness decision-making. 3) Whole Patient
Care – VET-Spirit serves as a model for integrating patient voices into care. Specific Aims:
Aim 1) Identify what and how providers (physicians, palliative care and POSH teams, chaplains)
want to receive data on Veterans’ spirital needs. Determine content, format, barriers and
facilitators to spiritual needs information delivery and its integration into care. Aim 2) Evaluate
the feasibility and acceptability of VET-Spirit among providers of seriously-ill veterans (e.g. stage
IV cancer, congestive heart failure, chronic obstructive pulmonary disease). Methodology: Aim
1 - qualitative methods of focus groups and in-depth interviews and directed content analyses of
those data will inform: work flow considerations, information delivery location, content, format,
conversation prompts, additional facilitators and barriers, and provider self-efficacy. Aim 2 -
qualitative and quantitative methods to determine VET-Spirit feasibility and acceptability.
Descriptive statistics will be calculated for all quantitative measures as well as trend change
scores in outcomes (e.g., provider self-efficacy, knoweldge). Acceptabiltiy and feasiblity
measures include: rates of VET-Spirit provider participation, veteran participants accrued,
enrolled and retained, number of VET-Spirit completions, number of chaplain referrals and visits,
acceptability if implementation measure (AIM), feasibility of implementation measure (FIM) and
implementation appropriateness measure (IAM) scores; and provider satisfaction with tool ease,
efficiency and self-efficacy in spiritual care communications (assessed qualitatively). Next
Steps: Results of this pilot will fill the datagap in spiritual care delivery and inform a large scale
Hybrid Type 1 Effectiveness-Implementation Trial of VET-Spirit.

Public health relevance
Seriously-ill veterans rely on spiritual and existential beliefs to cope with their illness, support their quality of life, and make critical decisions about their care. VHA Directive 1111mandates that assessment must identify the importance of spirituality and religion for the patient, how it affects care, and comprehensive follow up, when needed. To assist in compliance with this mandate our research team developed and validated the first quantifiable spiritual screening tool (VET-Spirit) designed specifically for seriously-ill veterans. It offers the means to identify needs, resources and the impact of beliefs on care and decision-making. The proposed study develops and evaluates the feasibility and acceptability of integrating VET-Spirit into care. While our ultimate goal is to improve unmet veteran spiritual needs, this proposal focuses on provider outcomes (physicians and advanced practice providers) of those with advanced serious illness.